Ultra-Sensitive Vapor Phase Hydrogen Peroxide Sensor for Decontaminating Pharmaceutical Manufacturing Facilities (2nd Admin Supplement Request)

Project Summary/Abstract
Physical Sciences Inc. (PSI) is developing a sensor that can accurately measure ppbv to ~1000 ppmv
concentrations of vapor phase hydrogen peroxide (VPHP). This sensor will be used for inline monitoring of
VPHP concentrations of barrier isolators used for fill/finish operations of parenteral drugs. The capability to
accurately and sensitively monitor VPHP is critical, as residual concentrations as low as 30 ppbv have
been shown to oxidize biologics and reduce their efficacy. The need to accurately monitor VPHP after
sterilization is critical to minimize its deleterious effects on biological drug products and potentially cause
shortages of high-demand biologic pharmaceuticals. In addition, batch losses due to VPHP contamination
results in higher drug costs and reduced revenue. Optical sensors based on tunable laser absorption
spectroscopy (TLAS) exist that can monitor VPHP concentrations with limits of detection in the ppbv range,
however the TLAS approach is prone to interference from water vapor which is present at concentrations
several orders of magnitude larger than the VPHP concentrations during the aeration phase of
decontamination. This impairs the accuracy of existing optical-based commercial instrumentation, and
makes it challenging to accurately quantify VPHP at ppbv levels. In addition, the sensors are not robust for
manufacturing scale operations, requiring highly trained users and frequent recalibration. In the Phase I
program, PSI demonstrated an innovative sensing approach that was capable of quantifying 38 ppbv of
VPHP in the presence of 20,000 ppmv water. This approach has broad dynamic range from ppbv to
1000 ppmv – far greater than current commercial sensors, enabling monitoring of VPHP concentrations
throughout the entire sterilization cycle with a single instrument. During the Phase II program, a portable
prototype sensor based on the benchtop experiment will be fabricated and tested in the laboratory and in
field testing on a barrier isolator and a vacuum freeze dryer. Field testing will occur at a company that
builds barrier isolators for the pharmaceutical industry. Laboratory studies will demonstrate a detection of
≤ 10 ppbv in 60 seconds of averaging, and the capability to measure up to ~1000 ppmv of VPHP. Software
will be developed to automate control of the sensor, enabling unattended operation – a critical element in
the path towards commercialization of the technology. Unattended operation of the sensor will be
demonstrated in field testing by the end of the program.

Public health relevance
Project Narrative The proposed R&D effort will result in sensor for vapor phase hydrogen peroxide (VPHP) that will be capable of monitoring residual VPHP after sterilization before finish/fill operations at parenteral drug manufacturer facilities. This will enable pharmaceutical manufacturers to minimize the loss or reduction in efficacy of biologic and cellular therapy pharmaceuticals due to oxidation from residual VPHP. The capability offered by this sensor will help to reduce shortages of high demand biologics and cellular therapeutics.